S. aureus virulence factor expression during kidney abscess formation

PROJECT SUMMARY
Antibiotic-resistant bacterial infections are becoming increasingly more prevalent, and Staphylococcus
aureus infections in particular have high rates of antibiotic resistance, prompting research into alternative
treatment strategies. S. aureus vaccines have been developed, but all have failed in clinical trials to date, likely
due to the ability of S. aureus to blunt the immune system and block protective immune responses. S. aureus
produces many virulence factors that promote disease, including an arsenal of toxins, which directly target and
kill host immune cells. Several S. aureus toxins specifically bind to human cells, and are not active in the
mouse, rendering it difficult to dissect the specific role of toxins in the disease process. Few models exist to
study interactions between S. aureus communities, the toxins they produce, and their human cell targets.
S. aureus causes a wide range of disease manifestations in the human host, from skin and soft tissue
infections to bacteremia and systemic spread to deep tissues. When S. aureus enters the bloodstream,
bacteria are trapped in the liver, and then spread to the kidney to form large lesions called abscesses.
Abscesses contain a central core of tightly clustered bacteria, with concentric layers of necrotic and live
neutrophils, and an outer layer of macrophages. Because it is difficult to penetrate abscesses with antibiotics,
they can persist follow drug treatment, and may represent one of the reservoirs responsible for recurrent
infections. Better understanding of the interactions between bacteria within these structures, and the
interactions with surrounding host cells, will be critical in developing future therapeutics to more efficiently
eliminate these structures.
This proposal will utilize fluorescent transcriptional reporters to determine the spatiotemporal
expression patterns of S. aureus toxin expression within kidney abscesses, and will also develop an in vitro
system to study host-pathogen interactions within abscesses. We hypothesize that direct interactions with
neutrophils, and diffusible antimicrobials from macrophages, promotes expression of virulence factors
specifically at the periphery of abscesses. We will utilize fluorescent reporter strains and
immunofluorescence microscopy to determine whether toxin expression patterns change over the course of
kidney abscess formation in our mouse model, and determine if this is dictated by the presence of neutrophils
and macrophages. We will also develop an in vitro model of abscess formation using 3D agarose droplets to
encapsulate bacteria and adhere host cells to the droplet surface. In this model, we will visualize the dynamics
of virulence factor expression in the presence and absence of mouse and human primary phagocytes using
live imaging fluorescence microscopy. Establishing these robust systems to study S. aureus spatial patterning
and host-pathogen interactions will enable us to uncover key S. aureus vulnerabilities, which could be
exploited to generate more efficacious treatments against this important human pathogen.

Public health relevance
PROJECT NARRATIVE Methicillin-resistant Staphylococcus aureus (MRSA) produces multiple different virulence factors that promote disease and blunt the host immune response, resulting in limited vaccine efficacy. Toxins likely play a critical role in limiting the host response, however our knowledge remains limited because many toxins are specifically active against human cells, and few model systems exist to study these interactions. Our proposal will utilize a mouse model of kidney abscess formation to determine the spatiotemporal dynamics of toxin expression during infection, and will utilize these results to validate a 3D in vitro abscess model to study interactions between clusters of replicating bacteria and human phagocytes, enabling future molecular studies dissecting the interplay between S. aureus toxins and their host cell targets.